Administrative Core

The LA CaTS Center Administrative Core has been set up to promote, support, and continually evolve the governance and administrative structure of the Center, to effectively facilitate the necessary leadership, tools and processes required to integrate and align the Cores of the Center and accomplish the mission of building research infrastructure to address health outcomes in Louisiana. The leadership of the Administrative Core is comprised of the LA CaTS Center Principal Investigator (Pennington Biomedical Research Center) and two Program Co-Directors (LSUH-NO and Tulane University Health Sciences Center), along with support and management staff at the three administrative offices. The Administrative Core coordinates and streamlines business and management functions across the network institutions with the goal of reducing barriers, obstacles, and helping to bridge research gaps. The Core will work to maintain and further develop the culture of trust established between the partners over the past two funding cycles; one that has been particularly conducive to fostering high levels of collaboration between investigators and institutions both within and outside the state. The Core's activities will also ensure effective two-way interaction with stakeholders and close collaboration with our community partners. For the 3rd funding cycle, the Administrative Core will work with the Steering Committee and Operations Committee to act on and provide resources to support and bring to fruition the scientific opportunities identified in the Center's strategic plan. These opportunities include but are not limited to 1) facilitating “team science” and clinical trial growth; 2) strategic faculty recruitment among LA CaTS Center institutions; 3) increasing community based participatory research; and 4) promoting precision medicine and nutrition initiatives. Importantly, the Center has secured substantial resources and responsibilities across a variety of public health priorities and will continue to devote efforts to monitoring, reporting, and building on research per NIH priorities. The Administrative Core will coordinate and offer the resources, activities and initiatives that will support investigators in their goal to accomplish the overall LA CaTS Center theme “from barriers to breakthroughs: innovative approaches to chronic disease management in Louisiana.”